Long term radiation treatment planning in brain tumors in the pediatric population

Project Summary and Abstract
Radiation therapy (RT) has a proven record of efficacy in treating many forms of pediatric brain tumors. However,
it is associated with long-term side effects due to damage to surrounding healthy tissue. This is especially
important in the pediatric developing brain, where long-term deficits can be seen in cognitive development. To
mitigate these deficits, there has been a shift from whole brain irradiation to more targeted treatment by using
dose painting intensity modulated radiation therapy. However, to use these techniques, more information is
needed about how giving radiation to normal brain structures, called organs-at-risk (OARs) affects outcomes,
both in terms of brain anatomy and function.
Voxel Healthcare LLC (VH) is the developer of ClickBrain – an automatic pediatric MR brain segmentation tool
that uses cloud-based deep learning (Google TensorFlow) technology for radiology clinical decision support.
Since the inception of this software, we extended ClickBrain to ClickBrain RT – a system that will combine
ClickBrain’s pretreatment brain structure segmentation outputs with radiation planning computed tomography
(CTs) and/or magnetic resonance (MRs) imaging to calculate dose to OARs. ClickBrain RT also segments
longitudinal MRIs to track outcomes via volumetric changes. In previous projects, we correlated input parameters
such as OAR dosing, demographics, tumor type and grade, OAR and tumor volumetric measurements to OAR
volumetric outcomes, using a database of brain MRIs from germ cell tumor patients. Here in Aim 1a, we will
modify our prediction using a hybrid deep learning and machine learning method for the prediction of treatment
outcomes for OAR. We will also be improving our autosegment algorithms. The tumor images extracted from
MRI and CT images will be concatenated with the patient specific demographic information (age and gender) for
the training of a hybrid neural network architecture. Imaging features will be sent to an autoencoder convolutional
neural network (CNN), while the demographic information will be sent to a densely connected multi-layer
perceptron (MLP) network. After individual feature extraction and reshaping, they will be concatenated and sent
to a MLP model for treatment late cognitive effects prediction. Missing data points will be synthesized using a
modified Pix2Pix Generative Adversarial Network (GAN) method. 3. In Aim 1b, we will build on our current
interface prototype, which uses clinical and demographic variables (age, chemotherapy dose, tumor type, grade
and location) and baseline imaging as input and outputs predicted outcomes for OARs. We will upgrade the
interface to provide full functionality and compatibility with existing commercial software for ease of porting files
between systems. Our extended validation in Aim 2 will focus on an existing large database from a broad range
of brain tumor patients acquired as part of standard-of-care and previous studies at Children’s Hospital Los
Angeles. Our long-term goal for ClickBrain RT is to train the machine learning algorithm to provide optimized
recommended OAR dosage ranges based on patient history and tumor information. Our software will allow
radiation oncologists to optimize treatment and vastly improve long-term quality of life in pediatric brain tumor
survivors.

Public health relevance
Narrative Radiation therapy is often a lifesaving treatment for pediatric brain tumor patients, but simultanously may cause radiation toxicity to surrounding healthy tissues in the brain. Mitigating tissue damage is necessary in order to avoid long-term developmental side effects to these children; our ClickBrain RT software will use deep learning technologies to automatically delineate key structures in the brain and predict volumetric changes that occur due to treatment-related radiation dosing to these key structures. This will help physicians to better avoid unnecessary radiation doses that may cause long-term deficits in children with brain tumors and can ultimately lead to better quality of life for these children.